BW 256U87 PROPHYLAXIS FOR OPPORTUNISTIC CMV IN ADVANCED HIV

This protocol compares valacyclovir to two doses of acyclovir in an attempt to prevent CMV disease in patients with advanced HIV. Patients are followed with 6 annual visits for approximately 3 years.